Near-infrared Fluorescent Probes for Sensitive Detection of NADH in Live Cells

Our proposal endeavors to secure the Shimadzu LCMS-2050 system, aiming to propel our
research in fluorescent probe synthesis for biomedical applications to new heights. This cutting-
edge instrument is poised to redefine our approach by offering real-time monitoring capabilities,
enabling the exploration of innovative reaction conditions, optimization of synthetic methods,
and rapid identification of lead candidates. The system's technical excellence lies in significantly
enhanced efficiency, streamlined processes, and reduced resource consumption. Beyond its
technical merits, this proposal underscores our commitment to spearheading impactful and
resource-efficient scientific innovation in our field. By investing in state-of-the-art technology and
adopting sustainable, responsible resource management practices, we are dedicated to advancing
our research at the forefront of the discipline. The strategic acquisition of this advanced
instrumentation positions our research group to pioneer groundbreaking fluorescent probes
using more efficient and eco-friendly synthetic methodologies.

Public health relevance
Our project endeavors to enhance the synthesis of fluorescent probes for biomedical sensing and imaging applications by integrating the state-of-the-art Shimadzu LCMS-2050 system, facilitating real-time monitoring and efficient optimization of synthetic methods, all while prioritizing sustainability and resource efficiency to reinforce our dedication to scientific innovation.